Mechanisms of Reverse Transendothelial Migration in Arthritis Resolution

3. Abstract
Inflammation is a beneficial response to infection or tissue damage and mediates the removal of
microbial pathogens and restoration of the tissue to homeostasis. Occasionally the inflammatory
response does not resolve properly and becomes a chronic process, resulting in diseases such as
arthritis, asthma, and many others. Significant effort has gone into developing therapeutics to block
the development of inflammation; however, these approaches also increase the risk of serious
infection due to simultaneous inhibition of the host immune defense against microbial pathogens.
Recent work has demonstrated that the resolution of inflammation is an active and dynamic process.
Neutrophils recruited to the infected/damaged tissue phagocytose and kill invading bacteria, undergo
apoptosis, and are cleared by macrophages (efferocytosis). Efferocytosis is a key component of the
resolution process and induces a switch from pro-inflammatory to anti-inflammatory processes in
macrophages. This switch results in decreased pro-inflammatory cytokine production, increased
production of anti-inflammatory mediators, enhanced efferocytosis, diminished neutrophil recruitment,
and promotes tissue healing and a return to homeostasis. Recently, however, another mechanism
has been described that may directly impact inflammation resolution, reverse transendothelial
migration of neutrophils (rTEM). In this mechanism, neutrophils that enter the tissue during
inflammatory responses do not die there, but rather re-enter the vasculature and travel to the lungs
before proceeding to the bone marrow where they ultimately die. This process appears to be at least
partially mediated by eicosanoids, specifically LTB4, PGE2, and LXA4. Our previous work has
demonstrated the failure of Lyme arthritis resolution in mice deficient in these inflammatory mediators.
Based upon our preliminary data, we hypothesize that neutrophils that enter tissues and encounter
microbes will remain in the tissues and undergo apoptosis there, if there are no microbes
encountered the neutrophils will undergo rTEM and exit the tissue. This proposal will investigate the
role of rTEM in inflammation resolution and the roles of LTB4, PGE2, and LXA4 in mediating this
response. Successful completion of these studies will provide new knowledge and understanding of
neutrophil trafficking during inflammation and the role of rTEM in inflammation resolution.

Public health relevance
Project Narrative The resolution of inflammation is a critical mechanism leading to the healing of damaged tissue and a restoration of homeostasis. Failure of resolution is now considered a primary driver of chronic inflammatory disease in many different tissues, yet we understand little about the regulation of resolution mechanisms. In this proposal we will examine the role of reverse transendothelial migration (rTEM) of neutrophils on resolution of Lyme arthritis.